The Penn Human Precision Pain Center (HPPC): Discovery and Functional Evaluation of Human Primary Somatosensory Neuron Types at Normal and Chronic Pain Conditions

Migraine, one of the most common primary headache disorders, affects 1 in 4 US households. This complex
neurologic disorder is mediated in part by alterations in trigeminal somatosensation, which manifests as head/fa-
cial pain and/or trigeminal allodynia. Effective treatments for migraine are still limited, and our knowledge about
human trigeminal system at baseline and migraine conditions are sparse. In response to RFA-NS-22-018, HEAL
Initiative: Discovery and Functional Evaluation of Human Pain-associated Genes & Cells, we propose to
form the Penn Human Precision Pain Center (Penn HPPC) to elucidate molecular, cellular, epigenetic, and
physiological profiles of human trigeminal ganglion (TG) sensory neurons at baseline and migraine conditions.
The Penn HPPC will be composed of Penn and international investigators with multidisciplinary expertise. The
PI, two MPIs, and two co-Is are currently collaborating on a single-soma deep RNA-seq of human dorsal root
ganglion (DRG) neuron project, which form a strong foundation for this application. Specifically, the Penn HPPC
will contain three cores and perform three projects. The administrative core will serve as a sole organizational
and administrative entity for the Penn HPPC. The human tissue core will function as the sole entity for procuring
and storing human tissues and distributing human tissues among research projects. The data core will be the
sole entity for storage, processing, and distribution of all data from the HPPC projects. In project 1, we will
employ three complementary approaches, a laser capture microdissection based single-neuron-soma deep
RNA-seq (a novel method developed by the PI’s lab, which has been successfully used with human DRG neu-
rons), 10 x Visium (a commercially available spatial transcriptomics platform), and MERSCOPE (another com-
mercially available spatial transcriptomics platform) to conduct single-soma RNA-seq of neurons and non-neu-
ronal cells of TGs from control donors and those with migraine. In project 2, we will perform two types of single-
nucleus multi-omics sequencing with TGs from control donors and those with migraine: chromatin accessibility
(ATAC plus RNA, 10x Genomics multiome assay) and DNA methylation (methylation plus RNA, snmCAT-seq).
In project 3, we will recruit migraine patients and control human subjects to conduct pain questionnaires, soma-
tosensory tests, blink reflex, and in vivo microneurography recordings of trigeminal and spinal sensory afferents.
Together, our proposed Penn HPPC will produce comprehensive and multi-dimensional datasets of human TGs
at baseline and migraine conditions, which will generate unprecedent molecular, cellular, and functional atlas to
understand normal trigeminal sensations and abnormal sensations associated with migraine. Our results may
also lead to discovery of new biomarkers for migraine diagnosis and/or identification of novel potential drug
targets for migraine treatment.

Public health relevance
In response to RFA-NS-22-018, HEAL Initiative: Discovery and Functional Evaluation of Human Pain-associated Genes & Cells, we have assembled a team of investigators with multiple disciplinaries to form the Penn Human Precision Pain Center (HPPC): Discovery and Functional Evaluation of Human Primary Somatosensory Neu- ron Types at Normal and Chronic Pain Conditions. The proposed Penn HPPC will conduct single-soma deep RNA-seq, spatial transcriptomics, and integrated single-nucleus multi-omics analyses of human TGs from nor- mal donor and those with migraine as well as perform sensory evaluations and in vivo recordings of sensory afferents with control human subjects and migraine patients. Our anticipated results would generate comprehen- sive epigenetic, molecular, cellular, and functional datasets to understand human normal trigeminal sensation and abnormal sensations associated with migraine.